MESA Family - Ocular Component

Recruitment of African American and Hispanic sbships for MESA Family began in May 2004. By the end of 2006, when enrolled was complete, 3026 shipships from 608 families were enrolled. [unreadable] On this MESA Family sample, phenotype annotation is basically complete and genotyping has been performed. Analytic work is slated to begin in late 2007 after genetic data cleaning has been completed. [unreadable] [unreadable] Genetic analyses on MESA index cases (from the original MESA cohort) are underway using both candidate gene and candidate-wide association strategies.[unreadable] [unreadable] For additional information about the MESA study, studies ancillary to it, and a list of collaborators, see http://www.mesa-nhlbi.org.